Shaping Pain:The Pain Resilience Project

Safe and effective treatment for pain remains a global unmet medical need, which in turn has contributed to the
opioid crisis. The experience of pain varies from person to person, with some individuals relatively resilient to
pain compared to others. Individual-to-individual variation in pain, while observed in the clinics, has not been
accurately modeled in the laboratory nor has its mechanistic underpinnings carefully examined. This is partially
because pain involves both detection by the peripheral nervous system and perception in the central nervous
system, and may be modulated by many factors including genetic, epigenetic, environmental and social.
Our studies thus far of blood relatives with inherited erythromelalgia (IEM) with varying degrees of pain despite
carrying the same Nav1.7 mutation (S241T), have allowed us to identify modulatory gene variants/mutations
expressed in sensory neurons using whole exome sequencing, and indict one specific gene, KCNQ2, and
suggest three additional genes, as modulators of pain in these patients. There are undoubtedly additional
molecules that influence DRG neuron firing and modulate pain.
In this proposed work, we will capitalize on our unique platform of induced pluripotent stem cell technology,
and access to additional families with IEM and varying inter-individual pain profiles, to identify modulatory
genes that might be developed into targets for the development of new pain treatments.

Public health relevance
Chronic pain is a major challenge for veterans with nerve and spinal cord injury, traumatic limb amputation, burn injury, and peripheral neuropathy. Current treatments for pain are largely ineffective or only partially effective, and can be addictive, which in turn has contributed to the opioid crisis. Rehabilitation of veterans with chronic pain would be substantially enhanced by the development of more effective, non-addictive treatments for pain. The proposed work will capitalize on a unique platform of induced pluripotent stem cell technology, and access to blood relatives sharing the same pain-causing mutations yet experiencing different degrees of pain, to identify genes that confer resilience to pain and pinpoint novel targets for the development of new treatments for pain. !